The role of SWI/SNF chromatin remodelers in homologous recombination and genome stability

Multiple subunits of the SWI/SNF chromatin remodeling complexes have been identified as a novel class of
tumor suppressors mutated in up to 20% of human cancers, but their mechanism of tumor suppression is still
poorly understood. These complexes are composed of a mutually exclusive ATPase subunit (either BRG1 or
BRM), a set of core factors, and a group of accessory subunits. SWI/SNF complexes were first identified as
transcriptional activators and therefore most of the research efforts have been focused on the role of these
ATPases in the transcriptional regulation of a variety of cellular pathways involved in carcinogenesis. More recent
work has linked BRG1 to DNA repair. We identified a complex containing TopBP1-E2F1-RB responsible for the
recruitment of BRG1 to DNA double strand breaks (DSBs). Moreover, we also identified a function for BRG1
stimulating DNA end resection and homologous recombination (HR) by reducing nucleosome density at DSBs
and promoting the recruitment of the CtIP nuclease. However, the role that the other ATPase (BRM) and other
non-catalytic subunits of the SWI/SNF complex may play in this function is still unknown. The goal of this proposal
is to further define the mechanism by which BRG1 and BRM stimulate DNA end resection and HR, to determine
to what extent SWI/SNF subunits ARID1A and BRD7 are required for this function, and to test whether we can
sensitize breast cancer cells to chemotherapeutic agents by inactivating these SWI/SNF subunits. Our
hypothesis is that BRG1 reduces nucleosome density at DSBs, thus allowing the recruitment of the DNA end
resection nuclease CtIP and stimulating DNA end resection and HR, and that ARID1A and BRD7 are important
for anchoring these complexes at DSBs. The uncovering of a function in DSB repair for SWI/SNF accessory
subunits could help explain their tumor suppressor activities. Moreover, identifying multiple SWI/SNF subunits
required for HR, would also identify a DNA repair vulnerability that could be exploited therapeutically against
SWI/SNF-mutated cancers. In order to test this hypothesis, we will, first, determine whether a BRG1- or BRM-
ATPase-dead mutant would be able to stimulate DNA end resection and promote the recruitment of the CtIP
nuclease. Second, we will define the role non-catalytic SWI/SNF subunits ARID1A and BRD7 play in the
recruitment of BRG1, chromatin remodeling at DSBs, DNA end resection, and HR, by analyzing the generation
of single-stranded DNA and ATR signaling after DNA damage. Third, we will determine whether we can sensitize
breast cancer cells to chemotherapeutic agents, including Poly (ADP-ribose) polymerase (PARP) inhibitors, by
inactivating BRG1, BRM, ARID1A, and BRD7 subunits. This systematic study of the function of the SWI/SNF
subunits in DNA end resection and HR will further our understanding of the biology of these complexes, their
functions, and the required composition of these complexes in order to perform this function in HR. Moreover,
we could potentially identify DNA repair vulnerabilities in SWI/SNF-mutated cancers that could be exploited
through specific chemotherapeutic regimens designed for HR-deficient malignancies.

Public health relevance
The proposed research will define the function of multiple SWI/SNF chromatin remodeling complexes subunits in the repair of DNA double-strand breaks, specifically in DNA end resection and homologous recombination. SWI/SNF complexes are mutated in up to 20% of cancers and their tumor suppressor activity is poorly understood. These studies could help us identify DNA repair vulnerabilities that can be exploited therapeutically in the treatment against cancers bearing SWI/SNF mutations.